Algorithms and Software for the Assembly of Metagenomic Data

Project Summary
The importance of the microbial communities inhabiting the human body cannot be understated, and currently,
metagenomic sequencing is one of the primary ways through which these communities are being analyzed.
While targeted assays exist, it is now widely accepted tha the analysis of the entire complement of genes
found within the microbiome (which can only be obtained through metagenomic sequencing) is critical for
understanding the role these microbes play in health and disease. An important analysis is metagenomic
assembly—the process used to stitch together sequencing reads into contiguous DNA sequences (contigs)
and metagenome-assembled genomes (MAGs). The reconstruction of full genomes can enable analyses of
the strain structure of communities, association of antibiotic resistance or virulence genes with specific
members of the community; and more. Thus, there is strong interest in the broader microbiome community in
methods able to extract high-quality MAGs from metagenomic data.
New technologies have made it easier to construct MAGs, however, significant challenges remain, particularly
for low abundance organisms and when handling genomic variation between bacterial strains. This proposal
will tackle such challenges, as follows. New assembly merging/reconciliation techniques will allow the
integration of data across different sequencing technologies and metagenomic samples, thereby improving the
recovery of the genomes of low abundance organisms. Such organisms are believed to play an important role
in defining the community structure and through their impact on human health. A valuable tool for mining
microbiome data sets is the identification of genomic segments shared across multiple samples, thus allowing
their association with clinical parameters and distinguishing them from transient members of the microbiota.
This project will develop new techniques for the discovery of conserved sequences, relying on statistical
analyses of k-mers and graph analyses to improve accuracy while maintaining computational speed. The
project will also address the fact that the genomes found in the samples may harbor a different combination of
genes from the pangenome of a species than represented in any one of the reference genomes. Proposed is a
new approach for using pangenome graphs to guide the assembly process, thus enabling the assembly
process to automatically "mix and match" between the genomic content of the reference collection, while also
improving efficiency by removing redundancy. Finally, this project proposes a novel graph-based paradigm for
the discovery of bacteriophages—viruses that infect bacteria and that play an important role in defining the
structure of microbial communities. Phages are also being considered a promising avenue for anti-bacterial
therapies as we face increased rates of antimicrobial resistance.
The approaches developed in this project will be implemented in usable and open-source software tools,
allowing both academic and industrial reuse, and the data generated will be made publicly available.

Public health relevance
Narrative Microbial communities play an important role in human health and disease. This project will develop techniques that enable a deeper exploration of human-associated microbiomes. In particular, the proposed research will lead to a better characterization of low abundance organisms as well as of the viruses that infect human-associated bacteria.